Novel Multiple-Stage Active Antimalarials

PROJECT SUMMARY/ABSTRACT
Natural products have been notably at the forefront of most approaches to combating many infectious
diseases. Many of the natural products have served as template for the design and development of
antimalarial drugs currently in the clinic or in the development phase. Recently we have developed a series of
novel antimalarial chemical entities inspired by the prodiginine and tambjamine natural products that meet the
following key criteria: 1) potent activities against liver stage and blood stage malaria parasites, as well as
inhibition of gamete formation; 2) orally efficacious; 3) curative in a single dose; 4) fast-acting; 5) long duration
of coverage; and 6) unique chemotype as compared to existing antimalarials likely operate by a novel
mechanism(s) of action. The ability to combat multiple stages of the infection with the potential of transmission
blocking represents a powerful tool, and one ideally suited to achieve the broadest possible benefit as a
renewed malaria eradication effort proceeds. Our proposed work in this application seeks to develop novel,
potent, safe, and inexpensive antimalarial drugs for both prevention and treatment of malaria, thus supporting
world-wide elimination of the disease. The specific goal of this project is to conduct lead optimization studies to
produce lead candidates for full preclinical testing that retain the broad-spectrum features and demonstrate
enhanced efficacy, safety and pharmacokinetic profiles that warrant further development.

Public health relevance
PROJECT NARRATIVE The impact of malaria is staggering, and the drug resistance to current therapies is growing at an alarming rate. As many as 300 million cases of malaria are diagnosed each year, killing half a million of children and pregnant women. There is a dire need for new and effective drugs in prevention, treatment and control of this deadly disease that act on multiple stages of the parasitic life cycle through novel mechanism. We have developed a novel natural product inspired antimalarial chemotype that is potent against multiple stages of malaria parasites, with the potential to circumvent drug resistance, prevent relapsing malaria infection, and block transmission. Our overarching goal is to develop a novel, potent, safe, and inexpensive antimalarial drugs for both prevention and treatment of malaria, thus supporting world-wide elimination of the disease.